Community Outreach and Engagement

SUMMARY
The Stanford Cancer Institute (SCI) is a national and international leader in cancer research across the cancer
control continuum, with a strong commitment to serving the more than 7.8 million people residing in our 10-
county catchment area in the San Francisco Bay Area through cutting-edge patient-centered cancer care,
innovative research, cancer-focused community outreach and engagement, and impactful policy advocacy (e.g.,
melanoma prevention, tobacco prevention). Our catchment area, where 79% of our patients reside, includes 10
geographically adjacent and highly diverse counties with respect to race/ethnicity, age, immigrant status, and
population density. Community partners, Community Outreach and Engagement (COE) staff, and SCI leadership
defined our high priority cancers for research and control over the short term (breast, lung, liver, pancreas, and
lymphoma) and long term (prostate, colon, and melanoma), as well as priority targets for cancer prevention,
including obesity and tobacco control. Significant accomplishments over the last 3 years include reaching more
than 13,000 community members through education and outreach activities, initiating new community
partnerships with a focus on Black/African American, Latinx, Asian/Pacific Islander, and LGBTQ+ communities,
facilitating innovative research projects in direct response to community needs, and providing customized
solutions to enhance clinical trials recruitment and retention. To address unmet needs in our catchment area
related to persistent health inequities and access to cancer care services and clinical trials, the SCI has
committed $1 million per year for the next five years to establish a new SCI Office of Cancer Health Equity and
Community Engagement (CHECE). CHECE is led by an executive team with deep and complementary expertise
in health equity research and translation (CHECE Director: Alyce S. Adams, PhD), clinical research and trials
accrual (CHECE Associate Director: Lidia Schapira, MD), and community-based participatory research and
practice (CHECE Associate Director: Lisa Goldman Rosas, PhD, MPH). Working collaboratively with our
Community Advisory Board, 70 community partners, SCI leadership, Stanford Health Care, Stanford Children’s
Health, and leaders in COE across Stanford University, CHECE seeks to improve the impact of COE on the
cancer burden and health equity in our catchment area. This will be accomplished through four main aims: 1)
Understand and monitor the cancer burden, cancer risk factors, and community assets in the catchment area on
an ongoing basis; 2) Develop and sustain bidirectional partnerships to facilitate research and activities that are
relevant to the catchment area; 3) Increase participation of underrepresented minority patients in SCI clinical
trials; and 4) Translate research into practices and policies that decrease the overall cancer burden and promote
health equity within and beyond the catchment area. The short and long-term impact of the proposed activities
will be evaluated using theoretically and empirically supported frameworks in close collaboration with community
partners and SCI leadership.